Functional Proteomics of Aging

Abstract/Summary
A group of investigators at the University of Minnesota seeks to renew “Functional Proteomics of Aging”, a
Training Program that helps exceptional young scientists develop the intellectual and technical tools needed
for productive careers as independent investigators and educators in aging research. The program has
supported annually 4 predoctoral and 2 postdoctoral trainees. The Training Program is in its 10th year of
funding and has trained 16 predoctoral and 9 postdoctoral trainees, who have successful careers. In addition
to the research conducted in the mentor’s laboratory, trainees receive didactic (4 courses, 2 workshops) and
experiential training in gerontology and proteomics (conferences, seminars, symposia, journal clubs, group
meetings with Program faculty members, and a new visitorship program to Nathan Shock Centers). The
experiential training is designed to maximize interaction among trainees and Training faculty from multiple labs
and with scientists involved in aging research outside the U of MN. Faculty mentors draw trainees from six
graduate programs at the University of Minnesota: Biochemistry, Molecular Biology and Biophysics (BMBB),
Chemistry (Chem), Experimental and Clinical Pharmacology (ECP), Integrative Biology and Physiology (IBP)
and Neuroscience (NSc), and Rehabilitation Sciences (RSc). The mentors’ research programs focus on the
use proteomic and other advanced state-of-the-art technologies to reveal the molecular details behind the age-
related loss in tissue function and/or age-related disease and are conceptually organized into four foci: loss of
muscle function with age and disease, decline of the central nervous system with age and disease, the
metabolism and signaling of aging and longevity, and development of technology for the advancement of aging
research. Our research is supported by outstanding cores equipped with a variety of state-of-the-art mass
spectrometers in the Center for Mass Spectrometry and Proteomics and bioinformatics platforms in the
Minnesota Supercomputers Institute. Training faculty laboratories also contain specialized analytical equipment
that is commonly shared between Program faculty. Together, the cadre of distinguished mentors, the extensive
interdisciplinary collaborations among faculty and trainees of multiple departments, the technological
resources, and the didactic and experiential training helps our trainees to shape successful careers.

Public health relevance
Project Narrative Current demographics suggest an impending health epidemic in age-related diseases, creating an urgent need for scientists trained specifically to investigate disease mechanisms. “Functional Proteomics of Aging” is a training program in basic and translational research in aging for both pre- and post-doctoral trainees. The program’s success in the last 10 years is documented by publications and successful research career trajectories of past pre- and post-doctoral trainees.